Stevens Johnson Syndrome/Toxic Epidermal Necrolysis (SJS/TEN) 2023

Project Summary
Stevens-Johnson syndrome and toxic epidermal necrolysis (SJS/TEN) is an immunologically mediated and
typically drug-induced disease defined by separation and necrosis of skin and mucosal surfaces. SJS/TEN
affects 1-5/million persons/year, and mortality in immunocompromised and elderly adults is up to 50%.1-3
SJS/TEN patients receive multidisciplinary care in the acute setting; however, their community and chronic
follow-up care is often fragmented or non-existent. Long-term disabilities affect their vision, mental and general
health, and quality of life and may leave them with limited safe future drug options.2-5 Although many research
advances have highlighted opportunities for prediction, prevention, earlier diagnosis, and more targeted
treatments for SJS/TEN, the relative rareness of the disease has created the need for coordinated
multidisciplinary research networks.5, 6 Particular stakeholders include dermatologists, burn and critical care
specialists, ophthalmologists, allergists and immunologists, pharmacists, pharmacologists, mental health
specialists and informaticians. Such multidisciplinary networking between researchers and a community of SJS
survivors and their families has been integral to the success of previous SJS/TEN meetings held in 2017, 2019,
and 2021. The meeting “Stevens-Johnson Syndrome/Toxic Epidermal Necrolysis 2023” planned to occur
virtually August 26-27, 2023 (also SJS Awareness Month), will build off the success of our past SJS/TEN
meetings in 2017, 2019, and 2021.2-5 To ensure the success of SJS/TEN 2023, our program highlights will
include community engagement, patient focus, and disparities in science and care. Like the 2021 meeting, the
2023 meeting will be held virtually due to ongoing global inequality in vaccines and safe travel access during the
COVID-19 pandemic. The scientific content of SJS/TEN 2023 will center around priorities identified in the 2021
meeting. These include 1) Prevention, prediction, and regulation; 2) Earlier diagnosis, risk stratification and
identification of the culprit drug; 3) Evidence-based short-term care and follow-up; and 4) Understanding
mechanisms and promoting innovation in care. Our outcomes will address concerns across diverse
constituencies of patients through broad community engagement throughout the program as well as dedicated
community and patient-focused sessions. Other products include expansion of the diversity of the engaged
scientific and community groups. In addition, we will build and measure the growth of multidisciplinary networks
leading to grant funding, publications, career development of new investigators, innovation, implementation, and
ongoing engagement with the SJS community. This meeting aligns with the broad mission of the NIH and
National Institute of Arthritis and Musculoskeletal and Skin disease to encourage treatment, prevention, and
research progress, research training of basic and clinical scientists, and community engagement.

Public health relevance
Narrative Stevens-Johnson Syndrome and toxic epidermal necrolysis (SJS/TEN) remain the severest of adverse drug reactions associated with an average acute mortality of 20% and significant long-term disability. Although SJS/TEN is relevant to a broad range of researchers and clinicians, there is currently no organized forum to foster focused networking, mentorship of early career and established scientists, cross-disciplinary research, and community engagement. Building on the success of the 2017, 2019 and 2021 meetings “Stevens-Johnson Syndrome/Toxic Epidermal Necrolysis 2023” will facilitate innovation, networking, and community engagement to highlight successes, opportunities, priorities and unmet needs from the perspective of scientists, clinicians, and community members.